Administrative and Leadership Core

Project Summary
The Administrative Core, Core A, of the Program Project “Alzheimer’s Disease and Related Disorders
Treatment and Outcomes in America: Changing Policies and Systems” will provide the leadership and
organizational structure to support and promote the scientific mission of the overall grant. Core A provides the
scientific and administrative direction to the various projects through a Steering Committee of project
investigators, assisted by a National Advisory Committee. Core A maintains internal communication among
investigators and committees, including maintenance of meeting minutes, schedules, and status reports as
well as external communication with federal officials and other constituents interested in project findings. Core
A also maintains and updates the P01 website, www.LTCFocus.org, which disseminates research findings and
de-identified project data. Additionally, Core A integrates pre- and post-doctoral fellows with aging and health
services research interests into the research team to expand the use of project data to a broader pool of
interested users. Core A is also responsible for administrative support, including budget preparation,
appropriate allocation of funds and monitoring of expenditures, initiation and management of contracts and
consulting agreements, preparation and submission of annual reports, assurance of compliance with human
subjects, scientific integrity, and financial policy requirements of the NIH, submission of Data Use Agreements
with the Centers for Medicare and Medicaid Services (CMS) and meeting CMS reporting and dissemination
requirements, and finally for liaison with and dissemination to external stakeholders and partners.